PATIENT EVALUATION FOR POTENTIAL AIDS CLINICAL TRIAL PARTICIPANTS

This is a proposal for a screening clinic for patients referred to the Infectious Disease Research Clinic. They will be informed of clinical trials which may be available. If no trials are currently underway, a blood sample will be obtained and a history will be performed.